A Multi-Modal Investigation of Neurophysiological Deficits in PTSD

Project Summary
Women are twice as likely as men to be diagnosed with posttraumatic stress disorder (PTSD), and sex hormones
have been implicated in this difference. While research has begun to elucidate neurophysiological contributions
to PTSD, there is a dearth of knowledge regarding how sex hormones influence these dynamics to confer greater
risk among women. For example, while PTSD is generally associated with increased resting state activity of the
dorsal anterior cingulate cortex (dACC) and decreased activity of the ventromedial prefrontal cortex (vmPFC),
women may exhibit lower activity in these regions compared to men. Other research has shown that PTSD is
associated with decreased functional connectivity of frontal brain regions. However, no prior research has
tested dACC-vmPFC functional connectivity in men versus women, which could provide insight into
mechanisms underlying PTSD sex differences. Further, low estradiol and high progesterone have been
associated with worse fear inhibition in women with PTSD, and testosterone levels have been implicated in
PTSD among men, though findings are mixed. No prior studies have examined how sex hormone levels
modulate dACC-vmPFC activity or functional connectivity in PTSD, and no studies have compared these
effects in men versus women. This proposed supplement will directly address these gaps by adding a new
sample of men to the ongoing Parent K23 study, as well as by adding testosterone assays to existing assays of
estradiol and progesterone. By examining the effects of sex hormones (estradiol, progesterone, testosterone) in
both men and women, this proposal will characterize the role of sex in the neurophysiological deficits
seen in PTSD. The proposed supplement will be embedded within the existing Parent K23 study, which has
recruited 60 women thus far. The supplement will include a new sample of 30 men with PTSD. The goals of
the Parent K23 and this proposed supplement are directly in line with Strategic Goal 1 of the 2019-2023 Trans-
NIH Strategic Plan for Women's Health Research: “Advance rigorous research that is relevant to the health of
women.” In particular, Objective 1.2 is to “Investigate the influence of sex and gender on disease presentation,”
and the proposed supplement will probe the role of three different sex hormones (sex) on
neurophysiological deficits in both men and women with PTSD.

Public health relevance
Project Narrative Women are twice as likely as men to be diagnosed with posttraumatic stress disorder (PTSD), and there is a dearth of knowledge regarding how sex hormones influence the neurophysiology underlying PTSD to confer greater risk among women. This administrative supplement will add a new sample of men, as well as testosterone assays, to the ongoing Parent K23 study (which is currently recruiting only women). This proposal will allow the applicant to characterize the effects of sex hormones (estradiol, progesterone, testosterone) on neurophysiological deficits in both men and women with PTSD.